Dose-Dependent and Region-Specific Impacts of siRNA mediated APP Knockdown on DNA Damage and Alzheimer's Disease Pathology

PROJECT SUMMARY/ ABSTRACT
Amyloid precursor protein (APP) represents a complex therapeutic target in Alzheimer's disease (AD),
as its processing generates both toxic amyloid-beta (Aβ) peptides and neuroprotective fragments like soluble
APP-α (sAPPα)1. While reducing APP through RNA interference shows preclinical and clinical promise for
decreasing Aβ burden2,3, the broader impacts of APP knockdown on essential cellular functions, particularly
DNA repair, remain unclear. In this proposal, I aim to investigate the dose dependent and region specific
effects of APP reduction on AD pathology and DNA damage in the AppSAA mouse model.
My study will utilize chemically modified APP-targeting siRNA administered via intracerebroventricular
injection at a low and high dose to examine how varying levels of APP knockdown affect AD pathology and
DNA damage in different brain regions. Through innovative techniques including Single-Strand Break mapping
using Next-Generation Sequencing (SSiNGLe) and MERSCOPE FISH spatial transcriptomics, I will map DNA
damage patterns and gene expression changes across different brain regions. This comprehensive approach
will be complemented by behavioral testing and molecular analyses to assess cognitive outcomes and
inflammatory responses.
I hypothesize that the effects of APP knockdown on DNA damage and AD pathology are dose
dependent and region specific, mediated by a balance between Aβ, APP, and sAPPα reduction. While reducing
Aβ through APP knockdown may decrease some aspects of AD pathology, the concurrent loss of APP and
sAPPα will worsen DNA damage and exacerbate AD pathology, particularly in vulnerable brain regions. The
findings from this study will advance our understanding of APP's role in AD pathology and normal brain
function, potentially leading to more nuanced therapeutic approaches that consider regional brain vulnerability
and the importance of maintaining essential APP functions while reducing toxic Aβ accumulation.

Public health relevance
PROJECT NARRATIVE While reducing amyloid precursor protein (APP) through RNA interference shows promise for decreasing toxic amyloid-beta in Alzheimer's disease, the broader impacts of APP reduction on DNA repair and region-specific vulnerabilities remain unclear. Using innovative techniques including Single-Strand Break mapping using Next- Generation Sequencing (SSiNGLe) and MERSCOPE FISH spatial transcriptomics in the AppSAA mouse model, I will investigate how different doses of APP-targeting siRNA affect AD pathology and DNA damage across brain regions, aiming to establish an optimal therapeutic window that maximizes the benefits of APP reduction while preserving its essential functions.